HUMATROPE IN THE TREATMENT OF SHORT STATURE DUE TO TURNER'S SYNDROME

The purpose of this study is to determine if Humatrope (somatropin), an investigational new drug, is effective alone and with low-dose estrogen in treating short stature due to Turner Syndrome. It will also help to show if Humatrope is safe for these children in these doses.